High Mobility Group A1 Chromatin Regulators in Colon Carcinogenesis

ABSTRACT & SPECIFIC AIMS (PARENT GRANT; score 4th%, Impact score – 2.0)
Background: We propose to elucidate molecular mechanisms mediated by High Mobility Group A1
(HMGA1) chromatin remodeling proteins during colorectal carcinogenesis. The HMGA1 gene is highly
expressed during embryogenesis, but silenced postnatally in most adult tissues. HMGA1 is also overexpressed
in diverse, poorly differentiated cancers and high levels portend adverse outcomes. HMGA1 proteins modulate
gene expression by “opening” chromatin and recruiting transcriptional complexes to DNA. While it is clear that
chromatin regulators help to govern nuclear architecture and cell fate decisions, the underlying mechanisms are
poorly understood. Here, we focus on HMGA1 in colorectal cancer (CRC).
Our scientific premise that HMGA1 fosters tumor progression in CRC is based on the following preliminary
results: 1) HMGA1 is highly overexpressed in CRC compared to non-malignant colonic epithelium, 2) Silencing
HMGA1 blocks oncogenic properties, prevents metastatic progression, and depletes cancer stem cells in
preclinical CRC models, 3) In transgenic mice, Hmga1 overexpression: a) induces hyperproliferation, aberrant
crypt formation, and premalignant polyposis in small and large intestines, and, b) expands the small intestinal
stem cell (ISC) pool by amplifying Wnt signals (Xian et al, Nature Comm; 2017), 5) Surprisingly, Hmga1 also
helps to “build” a stem cell niche by inducing Sox9 to generate Paneth cells, which support and nurture small
ISCs, 6) HMGA1 and SOX9 are positively correlated in human colon epithelium and both become markedly up-
regulated in colon cancer, and, 7) Inflammatory signals and procarcinogenic bacteria associate with Hmga1
expression in preclinical tumor models.
Together, these intriguing results support the following hypotheses: 1) Hmga1 is required for normal stem
cell function and tissue homeostasis in colonic epithelium, 2) Deregulated HMGA1 disrupts this equilibrium and
drives carcinogenesis and tumor progression through aberrant changes in chromatin structure and gene
expression, 3) Inflammatory signals and specific pro-carcinogenic bacteria induce HMGA1 to drive tumor
progession, and, 4) Identifying mechanisms linked to HMGA1 overexpression will reveal novel pathways that
could be modulated to treat, or even prevent, colon carcinogenesis.
Aims/Approach: To test this, we propose the following Specific Aims: 1) To define oncogenic and stem cell
phenotypes dependent upon HMGA1 in colonic epithelium, 2) To elucidate epigenetic alterations and genetic
pathways through which HMGA1 functions during carcinogenesis, and, 3) To determine whether targeting
Hmga1 is effective in mitigating or preventing colon carcinogenesis in preclinical models.
Impact: We expect to elucidate mechanisms that induce HMGA1 as well as downstream pathways governed
by HMGA1 in CRC. This work could reveal a new paradigm for colon cancer pathogenesis and lead to
novel approaches to treat, or even prevent, this formidable cancer.
SPECIFIC AIMS (PARENT GRANT)
1) To determine how Hmga1 overexpression alters cell fate and proliferation in colonic epithelium during
carcinogenesis. Here, we dissect the role of Hmga1 using our unique mouse and cell-based models.
2) To elucidate epigenetic alterations and molecular mechanisms through which HMGA1 functions
during carcinogenesis. A) To test the hypothesis that Hmga1 promotes carcinogenesis by inducing Wnt genes
and developmental transcriptional networks, we will integrate RNAseq, ChIPseq and ATACseq from colonic stem
and progenitor cells with knock-out (KO), overexpression (OE), or wildtype (WT) Hmga1 in mouse models. B)
To validate results in human colonic epithelium, we will interrogate TCGA databases and test the function of a
subset of HMGA1 transcriptional target genes in human organoid models.
3) To test the therapeutic efficacy of targeting Hmga1 to prevent or mitigate tumor progression in
preclinical models of CRC. Here, we compare colon tumorigenesis in mouse models + Hmga1 deficiency.

Public health relevance
NARRATIVE Colorectal cancer is the third leading cause of cancer-related death among both men and women in this country, and unfortunately, the incidence is rising. Tumors that are detected early are highly curable, while those that have spread to distant sites are associated with abysmal clinical outcomes. Here, we propose studies: 1) To determine why some tumors behave aggressively and spread to distant sites, and, 2) To begin to develop novel therapeutic approaches to treat, or even prevent, tumor progression.